IMMUNE MECHANISMS OF MIDDLE EAR DISEASE

Objectively define the extent and incidence of early and late phase responses to nasal allergen challenge with ragweed and its extensions, and correlate temporal patterns of these reactions with elaboration of inflammatory mediators in patients with allergic rhinitis.